Intrauterine mechanisms for liver metabolic disease in the growth-restricted fetus

PROJECT SUMMARY
The goal of this proposal is to advance our understanding of the mechanism for increased periportal collagen
deposition, a sign of developing fibrosis, in the liver of the fetus with fetal growth restriction (FGR) and the impact
on future liver metabolic disease. Children born with FGR have a higher risk of developing metabolic dysfunction-
associated steatotic liver disease (MASLD) and fibrosis in childhood and adulthood. A distinct feature of MASLD
presentation in pediatric patients, and one that is higher in FGR offspring, is localized fibrosis in periportal
regions. Previous studies demonstrate that hypoxemia-induced oxidative stress promotes hepatic fibrosis in
animal models. Yet, there remains a gap in our understanding of how oxidative stress in the fetal liver may
promote a fibrotic niche and future susceptibility to liver disease associated with fibrosis. Our preliminary data
indicate that FGR fetal sheep have increased hepatic periportal collagen deposition and increased markers of
oxidative stress signaling. In addition, our preliminary data in fetal sheep exposed to long-term hypoxia show an
increase in hepatic periportal fibrosis. I hypothesize that hypoxemia-induced oxidative stress in the FGR
fetus produces cell-specific and regional effects in the fetal liver that initiate periportal fibrosis. Overall,
this proposal will provide critical information for how FGR promotes hepatic fibrosis that persists postnatally. Aim
1 will Identify cell-specific and regional gene expression signatures in the fetal liver in response to FGR. Aim 2
will test if FGR and hypoxemia promote intrinsic fibrogenic capacity in hepatic stellate cells and test whether
treatment of an antioxidant, N-acetylcysteine, prevents hypoxia-induced activation. Aim 3 will determine if hepatic
fibrosis persists in postnatal lambs born with FGR. Expected Outcomes: This proposal will characterize the
impact of FGR on oxidative stress and fibrosis in the fetal liver. Importantly, completion of this proposal will
provide me with training in liver physiology and metabolism, bioinformatics, advanced histology, models to study
fetal development, hepatic stellate cell culture, and scientific writing to help me achieve my career goal as a
tenure-track assistant professor specialized in the fetal developmental programming of immunometabolism.
Impact: The aims in this proposal will be used to help understand how fibrosis develops in postnatal liver of FGR
offspring and determine future mechanistic experiments used to investigate fetal origins of fibrosis.

Public health relevance
PROJECT NARRATIVE Offspring born with fetal growth restriction (FGR) have increased incidence of metabolic dysfunction-associated steatotic liver disease (MASLD) and periportal fibrosis. The goal of this proposal is to advance our understanding of the mechanism for increased periportal collagen deposition, a sign of developing fibrosis, in the liver of the fetus with FGR and the impact on future liver metabolic disease. Results from this proposal will be used to help understand how fibrosis develops in postnatal liver of FGR offspring and determine future mechanistic experiments to investigate fetal origins of hepatic fibrosis.